Human Retinal Imaging Biomarkers for FTLD-Tau in Relation to FTLD-TDP and Nonamnestic AD

Project Summary/Abstract
Frontotemporal degeneration (FTD) is a progressive neurodegenerative condition as common as Alzheimer’s
Disease (AD) in those 65 and younger. There are no FDA approved medications for FTD, and development of
therapies is severely limited by the absence of adequate biomarkers for the causative pathology. Most cases of
FTD are caused by abnormalities related to the protein tau (FTLD-Tau) or the protein TAR DNA binding protein
– 43 (FTLD-TDP). However, it can be difficult to determine prior to autopsy which patients have abnormalities
from tau versus those with abnormalities from TDP-43. Furthermore, it can be difficult to distinguish prior to
autopsy those patients with FTD from those with nonamnestic AD (naAD). Clinical trials testing therapies
aimed at the underlying molecular causes of FTD are hindered by the problem of clinically distinguishing
FTLD-Tau, FTLD-TDP, and naAD. For these reasons, there is an urgent need to develop biomarkers for FTD
spectrum disorders as mechanism-based therapies emerge. Primarily using optical coherence tomography
(OCT), the objective in this application is to evaluate retinal image abnormalities as biomarkers that can
distinguish these proteinopathies and predict prognosis in the context of an interdisciplinary, deep
endophenotyping approach. Based on preliminary cross-sectional and longitudinal studies in FTD patients and
reports of inner retina thinning in AD and amyotrophic lateral sclerosis (a TDP-43 proteinopathy related to
FTD), the overall hypothesis is that the underlying tau, TDP-43, or amyloid β neuropathology of a particular
dementia may lead to specific abnormalities of the retina, an extension of neural tissue. OCT thus has potential
as a rapid, low-cost, and non-invasive biomarker. The proposed aims are: 1A) To determine if retinal
abnormalities, detected by OCT, are biomarkers distinguishing FTLD-Tau from both FTLD-TDP and naAD; 1B)
To determine if retinal abnormalities, detected by OCT, predict clinical outcomes; 2) To determine if dementia
relevant neuropathologies, as detected by histology and immunohistochemistry, are present in the retina of
eyes at autopsy in our cohort of FTD and naAD patients. With rigorous methodology, the investigators will
perform deep endophenotyping by ophthalmologists and neurologists, exclude confounding diseases, perform
cross-sectional and longitudinal OCT image analyses with a validated OCT image segmentation algorithm,
directly compare patient groups, and follow patients to autopsy of the brain and eyes. Developing retinal
imaging as a biomarker distinguishing FTLD-Tau from FTLD-TDP and naAD would be a significant contribution
because it would help resolve the current difficulty in properly enrolling FTD patients into clinical trials. This
research is innovative as it represents a significant departure from the status quo by taking an interdisciplinary
approach with careful phenotyping to determine if the retina is a biomarker for the underlying proteinopathy.
This project will open new horizons for biomarker models including OCT, and it will advance the use of retinal
imaging as a powerful biomarker for FTLD-Tau in relation to FTLD-TDP and naAD.

Public health relevance
Project Narrative The proposed research is relevant to public health because the development of retinal imaging as a biomarker for frontotemporal degeneration (FTD) pathology will enable proper enrollment of these patients into clinical trials testing mechanism-based therapies, thereby greatly improving the chance to find a treatment for these patients. Thus, the proposed research is relevant to the NIH’s mission to enable discoveries that will improve human health.